CCR2 Targeted Molecular Imaging and Treatment of Abdominal Aortic Aneurysms

Project Abstract
Abdominal aortic aneurysm (AAA) represents a life-threatening degenerative vascular disease. AAAs usually
remain asymptomatic until they rupture, leading to high mortality. AAA is more prevalent in men over the age of
65 years-old; however, AAA rupture occurs more often in women. The clinical imaging of AAAs largely centers
around measurement of AAA diameter, which is a poor marker for rupture prediction. There is an unmet clinical
need for a molecular imaging strategy to phenotype AAA patients for risk stratification. Monocyte chemotactic
protein-1/Chemokine (C-C motif) receptor 2 (MCP-1/CCR2) axis plays an important role in the pathogenesis of
AAAs by mediating the recruitment of inflammatory monocytes and infiltration of macrophages, resulting in the
degradation of aortic wall elastin and collagen. We have developed a CCR2-targeting radiotracer, 64Cu-DOTA-
ECL1i, for positron emission tomography (PET) imaging of CCR2+ pro-inflammatory monocytes/macrophages
and have demonstrated the specific detection of CCR2+ cells in patients with cardiovascular diseases. In murine
AAA models, 64Cu-DOTA-ECL1i PET demonstrated specific radiotracer uptake within the AAA wall that
correlated with sensitive detection of variations in CCR2+ cell populations. Marked elevation of radiotracer
uptake in rupture-prone AAAs demonstrated the potential of this radiotracer to assess AAA vulnerability.
Moreover, administration of a CCR2 inhibitor significantly decreased AAA progression and inhibited associated
rupture. We propose to assess CCR2+ inflammatory processes associated with AAA development and exploit
these processes as therapeutic targets in rodent AAA models, while exploring targeted CCR2 PET imaging in
AAA patients, by achieving the following specific aims. Aim 1. Assess 64Cu-DOTA-ECL1i PET for the
characterization of CCR2+ cell activity during AAA development and rupture in pre-clinical models. Aim 1A.
Correlate 64Cu-DOTA-ECL1i PET uptake with CCR2+ immune cell activity in vulnerable AAAs and changes in
the histopathological properties of murine AAA rupture models. Aim 1B. Optimize CCR2 antagonist treatment
regimens in murine AAA models and assess 64Cu-DOTA-ECL1i PET as a companion diagnostic to determine
treatment response. Aim 2. Determine the relationship between 64Cu-DOTA-ECL1i binding and CCR2+ cellular
composition using bio-banked human AAA specimens. Aim 2A. Determine the binding characteristics of 64Cu-
DOTA-ECL1i in ex vivo human AAA specimens and correlate these with associated histopathological features.
Aim 2B. Determine the relationship between 64Cu-DOTA-ECL1i tissue autoradiography, regional CCR2 gene
expression, cytokine profiles, and local matrix metalloproteinase activity. Aim 3. Assess the performance of 64Cu-
DOTA-ECL1i PET/CT to detect CCR2+ inflammatory cells in the human aorta. Aim 3A. Assess 64Cu-DOTA-
ECL1i imaging characteristics in AAA patients undergoing open repair and control, healthy volunteers to
determine the relationship between tracer uptake and molecular characterization of prospectively collected AAA
tissues. Aim3B. Assess the imaging reproducibility of 64Cu-DOTA-ECL1i PET/CT imaging in AAA patients.

Public health relevance
Project Narrative This project addresses the absence of a reliable diagnostic modality and medical therapy to prevent abdominal aortic aneurysm (AAA) growth and rupture in patients, leading to high mortality in those over the age of 65 years- old. Due to the pathogenic role of the monocyte chemoattractant protein-1 / C-C chemokine receptor type 2 (MCP-1/CCR2) axis in AAA, we propose to study the ability of 64Cu-DOTA-ECL1i PET/CT to predict the murine AAA rupture and serve as a companion diagnostic to assess CCR2 molecular therapy of murine AAA. We will perform the first-in-patient evaluation of 64Cu-DOTA-ECL1i PET/CT to image and detect AAA inflammation in a preoperative setting and acquire key biological information from AAA specimens collected at the time of open AAA repair, in order to assess the potential of 64Cu-DOTA-ECL1i PET in the management of AAA patients.